Mechanisms and Barriers in Nanomedicine-2023

In the recent years, remarkable progress has been made in the synthesis and characterization of
engineered nanoparticles for imaging and treatment of cancers, resulting in several promising
candidates in clinical trials. However, the nano drug delivery field needs a better understanding of
biological and immunological barriers, cancer pathology and immunology, and appropriate and relevant
models of disease. There is a growing sentiment in the field that there is need to revisit the basics and
to better understand the integrated biological, pathophysiological and immunological processes for
effective translation to nanomedicine design and performance. We propose to organize a conference-
workshop “Mechanisms and Barriers in Nanomedicine” in Golden, Colorado in May 2023. The program
will be focused on the following aspects: a) interactions at the particle interface; b) immune recognition
and toxicity of nanomaterials; c) relevance of models; d) in vivo barriers; d) new targets; d)
regulatory/industrial hurdles to translation. Leading experts will discuss the integrated roles of systems
immunology, protein corona, and tumor and vascular cell biology that modulate nanomedicine retention
and functionality in tumors. We strive to achieve the following goals: a) to provide an educational, yet
critical, forum into integrated biochemical and biological barriers controlling nanoparticle delivery and
their functionality; b) to present an update and potential paradigm shift on the strategies to mitigating
these problems; c) by conducting open, unrestricted, non-proprietary discussion among senior faculty,
young investigators and graduate students, we hope to trigger new ideas and concepts that will move
the field forward. The main innovation of the conference-workshop is in providing an open forum for
discussing problems with drug delivery and in the focus on biological, immunological and translational
aspects of nanotechnology. The R13 grant will be used to help with conference attendance for students
and postdocs, including underrepresented, racial and ethnic groups, individuals with disabilities,
individuals from disadvantaged backgrounds, and women.

Public health relevance
We propose to organize an international conference-workshop “Mechanisms and barriers in nanomedicine” in Colorado in May 2023. The workshop will be focused on biological, immunological, clinical and regulatory barriers of nanomedicine. The event will have a strong educational and scientific value for young scientists, postdocs and graduate students working in nano drug delivery and imaging.